Optimizing Diagnostic Strategies for TB Transmission Control in Health-Care Facilities

PROJECT SUMMARY
CANDIDATE. Dr. Ruvandhi Nathavitharana, is a physician and Instructor in the Division of Infectious Diseases
at Beth Israel Deaconess Medical Center (BIDMC). A 5-year K23 Career Development Award will provide the
necessary training and experience needed for her to become an independent investigator in implementation
science, with a focus on evaluating and optimizing the impact of tuberculosis (TB) diagnostics.
BACKGROUND. TB transmission in health-care facilities in high TB burden countries (HBCs) is a pressing
global health problem. A high prevalence of undiagnosed TB has been documented in hospitalized patients in
HBCs but TB infection control focuses on patients with known or suspected TB. FAST (Find cases Actively
using cough screening and molecular diagnostics, Separate safely and promptly Treat effectively) is an
intensified, refocused approach to decrease TB transmission that is being evaluated at Hospital Nacional
Hipolito Unanue (HNHU) in Lima, Peru (R01-AI112748, PI: Nardell). FAST improves case detection but is
resource intensive due to reliance on a high volume of sputum-based molecular tests. A cost-effective,
accurate, non-sputum based triage test is urgently needed to make FAST more feasible in HBCs.
RESEARCH. The overall objective for this K23 is to optimize active case finding strategies for TB in health-
care facilities in HBCs. The central hypothesis is that a simple, inexpensive, non-sputum based TB triage test
with a high sensitivity could have a major clinical impact by improving the performance and sustainability of a
transmission reduction strategy like FAST. Using an innovative hybrid study design nested within the parent
R01 study, this research will pursue three specific aims: 1) to determine the diagnostic accuracy of three non-
sputum based TB triage tests: digital chest x-ray using CAD4TB software (dCXR/CAD4TB), fingerstick C-
reactive protein (CRP) and exhaled breath testing (EBT) and determine which patients are missed by cough
screening, 2) to evaluate the cost-effectiveness of adding a triage test to FAST and 3) to evaluate the
implementation success of these triage tests in the context of FAST at HNHU and consider their potential role
in different clinical settings. This research will answer critical questions about the optimization of TB diagnostic
testing strategies in healthcare facilities and provide the foundation for an R01 diagnostic intervention trial.
MENTORING. Dr. Nathavitharana's primary mentor, Dr. Edward Nardell, is a TB transmission control expert
who has an established research partnership in Peru. They have assembled a multi-disciplinary mentoring
team across the Harvard network: Dr. Nira Pollock (a physician scientist with diagnostics expertise), Dr.
Stephen Resch (a cost-effectiveness expert) and Dr. Lisa Hirschhorn (a physician implementation scientist).
TRAINING. The research objectives are supported by a training plan that includes rigorous didactics and
coursework on diagnostic evaluation, decision analysis and implementation science, alongside a strong
institutional commitment at BIDMC and grant support and development program through Harvard Catalyst.

Public health relevance
PROJECT NARRATIVE Tuberculosis (TB) transmission in health-care facilities in TB endemic countries, primarily from patients with undiagnosed TB, is a pressing public health problem. Although molecular diagnostic tests such as Xpert MTB/RIF can improve TB case detection, they require a sputum specimen and their cost and infrastructure requirements limit their feasibility for testing large numbers of patients. Relevant to the NIH's mission to test reliable technologies to rapidly diagnose TB, this research will concurrently investigate the accuracy, cost- effectiveness and implementation of three non-sputum based TB triage tests, which could have an impact on improving the sustainability of TB transmission control strategies for health-care facilities.